Molecular Epidemiology in Children's Environmental Health Training Program

[unreadable] DESCRIPTION (provide by applicant) [unreadable] [unreadable] The Molecular Epidemiology in Children's Environmental Health (MECEH) training program began July, 2001 and is in its fourth training year. MECEH is defined as the use of biological, molecular and statistical measures in epidemiological research to determine how environmental exposures impact children's health at the physiologic, cellular, and molecular levels. As the offspring of epidemiology, medicine, statistical genetics, molecular biology, and molecular genetics, molecular epidemiology serves as an umbrella for focused research in genetic and biomarker epidemiology. MECEH has 3 participating departments: Environmental Health, Pediatric Medicine and Molecular Genetics. MECEH has had continuous full enrollment with 17 trained, 6 pre-doctoral, 8 M.D./MS fellows and 3 Ph.D./M.D. postdoctoral trainees. Seven have finished or are finishing by summer 2005 and have made great professional strides with national presentation, numerous publications, grant submissions and obtaining academic research positions. This application requests support for 3 additional trainees for the 5-years from 2006 to 2011, 1 pre-doctoral and 2 postdoctoral positions. [unreadable] [unreadable] The MECEH's long term objective is to increase the number of cross-trained epidemiologists, physician epidemiologists and molecular biologists who investigate high impact issues related to environmental exposures and complex childhood diseases. The overarching rationale for this training program has been stated in such federal initiatives as the Children's Health Act of 2000 (H.R.4365) which stressed "investment in tomorrow's pediatric researchers" (sec 1002). The MECEH has 3 primary goals: 1) provide a strong grounding in epidemiologic, statistical and wet and dry laboratory molecular methods, 2) prepare students for interdisciplinary research training and "enhance clinical research workforce training" as stated in the NIH roadmap, and 3) expand the trainee's expertise in statistical genomics, a rapidly developing area and a newer direction for this program. [unreadable] [unreadable] The public health significance of the MECEH program is directly correlated to the increasing national awareness of the rising number of environmentally related disease such as diabetes, obesity, asthma, neurodevelopmental disorders, and prematurity among others. Thus, the public health relevance of the program is great and is directly related to the need for researchers knowledgeable across disciplines in cutting-edge methodologies in the area of pediatric environmental health. [unreadable] [unreadable] [unreadable] [unreadable]